Investigation of Armadillo/ß-catenin Mechanisms Influencing Nociceptive Sensitivity in Drosophila

Project Summary
Normal pain promotes health by warning us of potential tissue damage, but abnormal pain reduces the quality
of life for millions around the world. Available treatment for pain is currently inadequate, in part because of the
deleterious side effects of our best analgesics, the opioids. Better treatments for abnormal pain are badly
needed. We propose to reveal novel targets for pain medications by exploiting the powerful genetic toolkit of
the Drosophila model. Fruit fly larvae react to noxious stimuli using an escape behavior consisting of an
unmistakable corkscrew roll. This model system has been used to identify dozens of components that regulate
nociceptive sensitivity. Many signaling components identified in the fly are very similar to their mammalian
counterparts. Preliminary results indicate that the fly homolog of B-catenin, called Armadillo (Arm) regulates
nociceptive sensitivity but the mechanism of this regulation is currently unclear. Aim 1 will test the hypothesis
that Arm regulates sensitivity by exerting its influence in the well-known Wnt/Wg transcriptional control
pathway. This testing will be accomplished by targeting RNAi silencing and/or overexpression constructs of key
pathway genes specifically to the nociceptor neurons using the Gal4/UAS system. Any resulting changes to
nociceptive sensitivity will be observed in thermo- and mechanonociception assays that focus on the escape
behavior. Aim 2 will test the independent hypothesis that Arm and related components regulate nociceptive
sensitivity through Arm's cell adhesion function. We will cause the nociceptors to express tagged forms of Arm
and other components that can be analyzed by immunofluorescent microscopy to study neuronal Arm's
contribution to neuronal-epidermal adhesive junctions called sheaths and to synapses with CNS interneurons.
We will under- and overexpress Arm and other components and correlate any changes in sheath or synapse
formation with nociceptive sensitivity using our behavioral assays. The proposed studies have the potential to
identify novel mechanisms and components that affect nociceptive sensitivity. Because of the high degree of
functional conservation between fly and mammalian signaling molecules, components identified by these
experiments may represent targets for novel medications for the treatment of abnormal pain in humans.

Public health relevance
Project Narrative: Available pain medications are inadequate to fully address the problem of intractable pain affecting some 10% of the US population. The proposed investigation aims to identify targets for effective new pain treatments by analyzing a pathway known to regulate nociceptive sensitivity in Drosophila. Drosophila is a powerful genetic model in which to efficiently identify the well-conserved genes that underlie basic processes like pain, allowing translation of these findings to mammals like rodents and humans.